MicroRNAs as Diagnostic and Prognostic Biomarker of Alzheimer's Disease

ABSTRACT
Preventative and therapeutic strategies for late onset Alzheimer’s Disease (AD) depend on access to reliable
biomarkers for early detection, ideally minimally invasive and inexpensive with more invasive and costly ones
reserved for subsequent diagnostics. Despite the progress in the development of blood biomarkers to detect AD-
associated beta-amyloid or Tau pathology, the challenges remain because AD is characterized by dysregulated
neural gene expression triggered by combinations of genetic and environmental risk factors. Genome-environment
interactions are orchestrated by epigenetic processes that include the function of microRNAs (miRNAs, miRs)
which is to regulate gene-expression and proteostasis. While altered microRNA expression is repeatedly observed
in AD biospecimens, small sample size and lack of mechanism maintain the gap of knowledge whethermicroRNAs
could serve as diagnostic and prognostic AD biomarker. The unprecedented combination of samples from
Alzheimer’s Disease Neuroimaging Initiative (ADNI), Framingham Heart Study (FHS), and Germany’s cognitive
impairment and dementia study (DELCODE) in this application provides us with the opportunity to bridge that gap.
In Aim 1we test the hypothesis that distinct patterns of circulating plasma microRNA levels differentiate among
cognitively normal (CN), individuals with mild cognitive impairment (MCI), and dementia patients (AD) meeting
clinical criteria for AD. Cross-sectional plasma samples for microRNA-Seq analysis were obtained from 847
participants in ADNI-1/GO/-2 and from 585 participants in DELCODE. We will use complementary computational
approaches to compare: AD vs CN, MCI vs CN, and AD vs MCI samples and identify microRNA signatures of MCI
and AD. The results will be integrated with the data from the FHS cohort comprising 48 participants with diagnoses
confirmed postmortem and 3 longitudinal plasma samples separated by years; the participants who developed AD
provided 2 samples before and 1 after their clinical AD diagnosis. We will use statistical and machine learning
approaches to generate miRNA-based classifiers. Aim 2 will determine if differential expression of circulating
candidate biomarker miRs that discriminate between AD and CN subjects can be observed in vulnerable cells, laser-
microdissected from postmortem cortices of Aim 1 FHS participants. In these cells we will quantify the expression
of miR-181a-5p, miR-148-3p and miR-146a-5p, a 3-miR plasma signature that uncovered patients at risk for
converting from MCI to AD in our exploratory study in press. We will also examine the expression of at least 3 top
microRNA AD biomarker candidates validated in Aim 1 analyses. In Aim 3 we will uncover the functions of
candidate biomarker microRNAs in vitro and in vivo by manipulating levels of biomarker candidates to establish
their functional readouts in human induced pluripotent stem cell- derived cortical neurons and glia and in next
generation AD mouse models. Our comprehensive interdisciplinary analyses will integrate observational and
experimental data to determine how MCI- and AD-associated microRNA signatures reflect AD-associated
pathology and serve as a biomarker for developing AD.

Public health relevance
Project Narrative Preventative and therapeutic strategies for late onset Alzheimer’s disease (AD) depend on access to reliable biomarkers for early detection. AD is characterized by dysregulated neural gene expression triggered by combinations of genetic and environmental risk factors which disrupt epigenetic control and alter microRNA expression. The unprecedented combination of samples from cross-sectional and longitudinal studies, Alzheimer’s Disease Neuroimaging Initiative, Framingham Heart Study, and Germany’s cognitive impairment and dementia study, enables us to study microRNA expression in human plasma and brain tissue samples in combination with functional studies in experimental models and determine how microRNAome signatures in mild cognitive impairment and AD reflect AD pathology and serve as a biomarker for developing AD.